Rutgers Mass Spectrometry Center for Integrative Neuroscience Research

? DESCRIPTION (provided by applicant): Previous funding from the NINDS P30 Program has supported the NeuroProteomics Core Facility of UMDNJ. With the integration of Rutgers University and UMDNJ, we now request support for an expanded Rutgers Mass Spectrometry Center for Integrative Neuroscience Research. Rutgers has outstanding depth in neuroscience with over 350 researchers in this area and in the past funding period, the Core successfully advanced neuroscience research and educational missions by providing NINDS researchers access to advanced proteomics technologies, and serving as a hub for collaborations and new technology developments. In this renewal application, we will provide NINDS-funded PI's with local access to state-of-the-art proteomics technology with the continued upgrade our Core equipment. Scientific Cores will be located on the Newark and New Brunswick/Piscataway campuses of Rutgers University and respectively directed by Co-PI's Dr. Hong Li, who has over 10 years' experience in managing the NeuroProteomics Core and Dr. Peter Lobel, who has extensive experience in using proteomics in neuroscience research. Expertise and technology of the two cores are complementary, but a key rationale for two locations is that NINDS researchers will be able to access the Core locally. This will allow interaction between researchers and facility staff that is critical for the successful planning, execution and interpretation of MS studies. Technical capabilities will be expanded for NINDs researchers with access to two new Thermo Q Exactive Hybrid Quadrupole-Orbitrap Mass Spectrometers. This is a high-sensitivity/high-throughput instrument that is highly applicable for protein identification, quantification of protein post-translational modifications and biomarker discovery and validation. Rutgers has promised excellent institutional commitment for the Core including modern laboratory space and salary support for both PIs and administrative supporting personnel. Two committees, composed of NINDS and other investigators, will oversee the facility's fiscal and scientific management as well as its daily operation. A User Club will provide an important forum for education, training, data sharing and collaborations. As demonstrated by our past record of success, this expanded Core will be maintained with a sound scientific and financial management structure and effectively utilized to enhance research capabilities for NINDS-sponsored research.

Public health relevance
PUBLIC HEALTH RELEVANCE: We are requesting NINDS funding to support the Rutgers Mass Spectrometry Center for Integrative Neuroscience Research. This center will improve our researchers' ability to study protein functions in nerve cells and abnormalities in neurodegeneration, aging and other diseases.